Prenatal Exposure to Metal Mixtures: Childhood Adiposity and Adipokines

PROJECT SUMMARY
Prior studies have identified associations between prenatal exposure to single classes of endocrine
disrupting chemicals (EDCs) and the development of metabolic disease. However, few studies have examined
the effect of mixtures of chemicals on perinatal and pediatric outcomes, despite evidence that pregnant women
are exposed to multiple EDCs simultaneously that share mechanisms of action. The proposed research will
examine environmental mixtures using novel statistical methods to evaluate the effect of prenatal exposure to
mixtures of metals, some of which are known EDCs and obesogens, on metabolic trajectory of children during
development. It will also evaluate the effect of these metal mixtures on telomere length and mitochondria DNA
copy number (mtDNAcn), as biomarkers of oxidative stress and inflammation, during pregnancy and at birth,
which may mediate the development of childhood adiposity. This study will harness already collected data from
Project Viva, a longitudinal prospective pre-birth cohort designed to examine the extent to which events during
early development affect health outcomes during the life course. Over two thousand mothers were enrolled in
the study at their initial prenatal visits in eastern Massachusetts between 1999 and 2002, and detailed
interviews, questionnaires, and sample collection was performed during pregnancy, at birth, and at distinct
developmental time points. The proposed analysis will use data collected during pregnancy, at birth, and at
ages seven (mid-childhood) and twelve (early adolescence). Prenatal metals have already been measured and
quantified in maternal red blood cells (RBCs) collected during the first trimester of pregnancy. These include
six nonessential metals (arsenic, barium, cadmium, cesium, mercury, lead) and four essential metals
(magnesium, manganese, selenium, and zinc). A major strength of Project Viva is the unique characterization
of weight gain and adiposity, which was measured longitudinally using sensitive measures of adiposity and
metabolic function. We will use levels of adipocyte-secreted hormones in cord blood, including leptin and
adiponectin, to assess metabolic function at birth and DXA scan measurements to objectively assess adiposity
at ages seven and twelve. We will use mtDNAcn and telomere length, measured prenatally during the second
trimester of pregnancy and at birth, as biomarkers of oxidative stress and inflammation. These biomarkers will
help elucidate the potential molecular pathway mediating the association between EDCs and childhood
obesity. The research outlined in this proposal will contribute to the limited knowledge regarding the cumulative
effects of in utero exposure to multiple EDCs and may identify potential new targets for intervention in pregnant
women.

Public health relevance
PROJECT NARRATIVE This study will examine the effect of prenatal exposure to mixtures of metals on adipocyte-secreted hormones at birth and adiposity during childhood. This is one of the first studies to use molecular biomarkers to examine if oxidative stress and inflammation mediates the association between in utero metals exposure and childhood obesity. Results of this study will provide insights into the combined effect of prenatal exposure to multiple endocrine disrupting chemicals on postnatal metabolic disease development and guide public health practice and policy, which has historically relied on the examination of a single chemical at a time.